An exploratory study of a new pH-responsive, ionizable hybrid nanocarrier for enchancing drug accumulation in bacterial biofilms

PROJECT SUMMARY/ABSTRACT
Description. Our goal is to study the feasibility of a newer, potentially safer and better nanocarrier design for
enhancing the delivery of a variety of therapeutic agents to bacterial biofilms. Biofilms are the main culprit
causing the majority of chronic wounds. Once established, biofilms can protect the encased bacteria against
immune system and most antibiotics, thus rendering the biofilm-associated infections very difficult to treat.
Despite the advance of antibiotics and development of new anti-biofilm agents, the first and foremost challenge
remains to be delivering enough drugs into the biofilms. This is a realistic need as much higher drug
concentrations are needed for effective treatment of the bacteria in biofilms than in their planktonic state.
Considering that many mature biofilms produce a microenvironment more acidic than the surrounding host
tissues, in this application we propose to exploit this biofilm characteristic by developing a new hybrid
nanocarrier design with a poly(lactic-co-glycolic acid) (PLGA) core coated with pH-responsive, ionizable lipids.
We hypothesize that: (1) by decorating PLGA with ionizable lipids that turn cationic in an acidic
microenvironment, the resulting “hybrid” nanocarrier will be well-retained in a biofilm, yet stay nearly neutral
outside to avoid excessive binding to the negatively charged host cell surfaces, and (2) with the lipid coating,
the PLGA core will still preserve its proven capability to encapsulate a wide range of different drugs. Moreover,
this nanocarrier may also have enhanced interaction with the negatively charged bacteria cell surface. Driven
by these hypotheses, the following aims are developed: (1) Develop efficient, stable ionizable hybrid
nanocarriers capable of entrapping diverse therapeutic agents for anti-biofilm therapy. (2) Verify and optimize
the impact of decorating nanocarriers with pH-responsive, ionizable lipids on their distribution and retention
in biofilms. (3) Evaluate the feasibility to enhance anti-biofilm activities of antibiotics and quorum sensing
inhibitors with pH-responsive, ionizable hybrid nanocarriers.
Relevance to Public Health. Biofilms are nearly ubiquitous and can form on the surfaces of most medical
devices and host tissues, resulting in a high incidence of device-related infections and tissue-related infections.
They are a critical barrier against effective drug treatment of many chronic infections such as delayed wound
healing, cystic fibrosis, endocarditis, urinary tract infections, etc, and are also responsible for bacteria
dissemination through the biofilm dispersal mechanism, as well as promoting other diseases including cancer.
However, up to date there is no drug officially approved for biofilm eradication. Successful completion of this
project will validate the feasibility of a new nanotherapy that can increase the selectivity of antibiotics and
antibiofilm compounds for biofilms, prolong their retention there and avoid excessive distribution to the host
tissues. Consequently, the effectiveness and safety of biofilm therapy can be significantly enhanced.

Public health relevance
PROJECT NARRATIVE In this project, we will develop a new nanocarrier (small devices about the size of one millionth of a millimeter) that can carry combination of antiretrovirals to the bacterial biofilms (aggregates of bacteria grown on patients' tissues or medical devices) in a specific and efficient manner. The proposed nanocarrier is designed to respond to the acidity in the biofilms and turn from neutral to positively charged, so it will accumulate within the negatively charged biofilms by electrostatic attraction to achieve high drug levels there. Successful completion of this project will have a major impact in advancing the treatment of various biofilm-associated infections which often respond poorly to the current antimicrobial therapy.